Tulane Program to Advance Representation in Minority Health Research (ARMHR)

7. Project Summary/Abstract
The Tulane Program to Advance Representation in Minority Health Research (Tulane ARMHR) builds on the
foundation of the past 13 years of funding through the Tulane-Xavier MHIRT Program to provide mentored
research training experiences for graduate students from groups that are underrepresented in biomedical,
behavioral, and social science research, and to encourage participants to pursue research careers in these
disciplines. Scholars from minority groups based on race, gender or sexual orientation, and socio-economic
disparities are eligible to apply. Each year AMRHR, will provide research training for two doctoral candidates
for extended 12-month research experiences and six masters and/or doctoral students for short-term 10 to 12-
week research experiences. Trainees are placed either in New Orleans area research sites or at international
sites affiliated with collaborative research projects led by program faculty. New Orleans-based trainees will
benefit from a rich environment of opportunities through Tulane-affiliated programs, including studies of the
impact of the physical and social environment on nutrition, obesity, and physical activity through the Prevention
Research Center; research on health promotion and advocacy to improve health for women, children, and
families through the Mary Amelia Women’s Health Center; and the KATIVA NOLA longitudinal studies of
resiliency in diverse New Orleans communities impacted by Hurricane Katrina, including first-generation
Vietnamese-American families. The current program maintains the most successful international sites from the
Tulane Xavier MHIRT Program, in Peru where the largest number of former trainees were placed and where
faculty maintain many active NIH-funded research and training programs, and in Cuba where our program has
critical institutional collaborations that allowed us to be the first NIH training program permitted to place
students in that country. The addition of new established research sites in Sierra Leone, a West African
country with many historical ties to the United States, and the Dominican Republic, a country colonized by
people of African descent with a long history of Spanish cultural influences, provides rich opportunities for
comparative studies in health disparities and social determinants in these diverse sites. Scholar research
plans are tailored to the primary research agendas at the individual overseas site, based on the funded
research programs active at each site. Prior to the research experience, ARMHR scholars receive training and
mentoring designed to foster improved self-efficacy, knowledge, and interest in research with a focus on health
disparities with a global and US lens. All trainees participate in a standardized research training program prior
to site placement, including a biweekly seminar series on research methods, an extended research planning
process with faculty mentors, and an individualized five-year research career plan. Following the research
experience, the cohort of scholars will meet to synthesize findings across experiences and sites in order to
identify common themes rooted in health disparities.

Public health relevance
8. Project Narrative The Tulane Program to Advance Representation in Minority Health Research (Tulane ARMHR) builds on the foundation of the Tulane-Xavier MHIRT program, first launched 13 years ago. Combining training, mentoring, and a real-world research experience, ARMHR’s goal is to promote research careers for underrepresented minorities by fostering self-efficacy, knowledge, and interest in research on health disparities.